Training Program in Developmental Biology

DESCRIPTION (provided by applicant): We are requesting support to train both pre-and postdoctoral students pursuing molecular, genetic and embryological studies in a Developmental Biology Training Program (DBTP) at Vanderbilt University involving a large trans-institutional and highly collaborative group of established investigators. We offer trainees a strong program foundation that includes: (1) Fifteen outstanding faculty from multiple departments who use advanced molecular, cellular and genetic approaches to study embryonic development in a variety of organisms (including C. elegans, Drosophila, Xenopus, zebrafish, chicken and mouse). (2) An interactive infrastructure of state-of-the-art laboratory, core and specialized facilities. (3) A commitment to producing well-rounded program graduates who are able to excel in any aspect of science that they choose to pursue. Developmental Biology Predoctoral trainees will receive: (1) Two years of rigorous training in a preceptors laboratory, (2) Specialized and elective courses in developmental, molecular and cellular biology that address fundamental scientific questions in relation to experimental organisms. (3) Exposure to research seminars given by students, faculty, and invited guests, and (4) Attendance at the Annual DBP Scientific Retreat, which is organized by pre-doctoral students. DBP Postdoctoral trainees will also spend two years in rigorous training and participate in Program journal and research clubs and retreat, and attend meetings and conferences. Additionally, they will attend periodic training sessions for resume writing, grant writing, publication preparation, interview skills and laboratory management. They will also have opportunities to teach classes and participate in review sessions, mentor graduate students and junior postdoctoral fellows.